More than just a load control: cytoskeletal form and function during aging

Project Summary. Although the cytoskeleton has historically been understood as the structural framework of
the cell, the proper function of actin is also required for a diverse array of cellular pathways. The collapse of
these cellular processes manifests during aging and exposure to a myriad of stresses, which is in part due to
the breakdown of the cytoskeleton under these conditions. Interestingly, the breakdown of the cytoskeleton
throughout age has been adopted as common knowledge in the field of aging biology, despite the lack of clear
and direct evidence. A major contributor to the lack of these essential studies is the lack of tools available for in
vivo, live-cell imaging of the actin cytoskeleton in multi-cellular organisms. Early in my postdoctoral career, I
developed a system for robust, tissue-specific, live-cell imaging of the cytoskeleton in the muscle, intestine,
and hypodermis of C. elegans, utilizing LifeAct fused to a fluorescent molecule. LifeAct-mRuby reliably binds to
F-actin, allowing visualization of functional, filamentous actin in the cells it is expressed. Using this system, I
performed an exhaustive characterization of the decline of actin cytoskeletal integrity during aging.
This work laid the foundation of my currently ongoing work in identification of novel regulators of the actin
cytoskeleton. Having set up a system to interrogate cytoskeletal quality, I can now interrogate novel genes in
their potential role for actin regulation. Using this and other platforms, I performed a multi-pronged screening
approach to identify novel genetic regulators of actin. These studies combined in vivo live cell imaging of actin
filaments, synthetic lethality screening with known regulators of the actin cytoskeleton, and both transcriptome
analysis and whole genome CRISPR-Cas9 screening of organisms experiencing actin stress. Cross-referencing
these rich datasets has revealed two critical nodes of genes: 1) modifiers of chromatin state and their
downstream transcriptional regulators and 2) genes involved in lipid storage and global lipid homeostasis.
In Aim 1.1, I hypothesize that a general chromatin state exists to promote a healthy transcriptome for
proper cytoskeletal form and function, and that this breaks down as a function of age. Moreover, a healthy
metabolic state can work either upstream of – or independent of – chromatin remodeling to also promote
cytoskeletal health. In Aim 1.2, I propose to study whether any of the identified processes can function in a tissue-
specific manner and a cell non-autonomous manner, by answering two questions: 1) is overexpression of
chromatin remodeling or lipid homeostasis factors in a single tissue sufficient to preserve organismal lifespan?
and 2) does overexpression of these genes in neurons drive protection of the actin cytoskeleton in peripheral
tissue? Aim 2 uses 2 biochemical approaches to assess cytoskeletal function. First, proximity labeling will be
used to characterize novel protein interactors of actin important for proper form and function. Second, we are
building a tool for a biochemical approach for quantifying actin function with single cell resolution. This study will
open exciting avenues of research in understanding the role of cytoskeletal function on physiological aging.

Public health relevance
Many cellular functions, such as autophagy, organelle dynamics, and endocytosis/exocytosis, as well as their dedicated quality control machineries, such as the ubiquitin-proteasome system and the heat-shock response, decline in efficiency and function during the aging process. The actin cytoskeleton is no exception, and exhibits marked decline in structural integrity and function at old age. I propose a multipronged approach to understand how the regulatory network involved in cytoskeletal maintenance deteriorates during aging, and how this contributes to the physiological consequences of aging.